Regulation of Lymphatic and Vascular Remodeling in Acute Kidney Injury

PROJECT SUMMARY: This NIH F30 application describes plan for mentored research and career development
for the PI, Gelare Ghajar-Rahimi. The scientific premise of this proposal is focused on the response of the kidney
endothelial system to acute kidney injury (AKI), a major complication in up to 20% of hospitalized and 60% of
critically ill patients. Despite the high mortality rate and incidence, targeted therapies to treat AKI have not been
successfully developed. Homeostasis of lymphatic and blood endothelial cells is vital to maintaining kidney health
and influences AKI pathogenesis. In response to injury, kidney lymphatic vessels (LV) undergo a process of
expansion termed lymphangiogenesis (LA) that mitigates kidney damage; density of peritubular blood capillaries
decreases, contributes to sustained hypoxia and impairs kidney function. Enhancing LA while simultaneously
impeding peritubular capillary rarefaction therefore holds immense promise as a therapeutic approach. These
two populations have never been studied concurrently in the context of AKI, limiting our ability to develop
endothelia-modulating therapies. Here, I aim to elucidate the cellular origins of de novo LA and the mechanisms
governing the endothelial remodeling following AKI. My preliminary data and existing literature suggest that 1)
de novo LA arises from a progenitor population of pre-existing lymphatic endothelial cells (rather than myeloid-
lineage as some older studies posit) and 2) the divergent responses of blood and lymphatic endothelial
populations to injury may be explained by the influence of NF-kB signaling within injured proximal tubule cells.
My central hypothesis is that that damaged proximal tubules, through NF-kB signaling, promote transcriptional
changes in endothelial cells that contribute to lymphatic expansion and vascular rarefaction. I will test this
hypothesis through advanced microscopy and single cell transcriptomics and a variety of in vitro and in vivo
experiments, including the use of an inducible lymphatic reporter mouse and mice deficient in NF-kB expression
in proximal tubules. These findings will significantly advance our understanding of the mechanisms by which
kidney endothelial populations respond to injury and could establish NF-kB as a novel therapeutic target in AKI.
The proposed training plan for the PI is sponsored by co-mentors Anupam Agarwal, MD, and James George,
PhD. Included in the training plan are experiences that will help Gelare develop in three major areas: 1) rigorous
lymphatic and kidney research, which includes developing familiarity with the existing literature, critical evaluation
of data, and training in the responsible conduct of research; 2) rigorous training in advanced bioinformatics and
next-generation sequencing analysis and 3) career and professional development, including grant and
manuscript writing, scientific communications, and the translation of research findings to clinical applications.
This proposal drives the development of skills required for rigorous scientific research, critical molecular biology
and advanced bioinformatics skills necessary for the PI’s future career as a physician-scientist focused on
cellular and molecular mechanisms of disease.

Public health relevance
PROJECT NARRATIVE Acute Kidney Injury (AKI) is a serious clinical problem that affects ~20% of hospitalized patients and 60% of critically ill patients while increasing risk of developing chronic kidney disease. The overall goal of this project is to understand cellular and molecular mechanisms that govern how lymphatic and blood endothelial cells in the kidney respond to injury and impact AKI pathogenesis. Understanding the response of the kidney endothelial subpopulations to injury in relation to other cell types in the kidney will have a significant impact on our ability to design novel, targeted therapies for AKI.